Synthetic rescue of antigen-driven T cells and alloimmunity

During graft-versus-host disease (GVHD), donor T cells require the histone
methyltransferase Ezh2 for producing and sustaining effector T cells that mediate host tissue
injury. We recently established that Ezh2 serves as a molecular gatekeeper for the generation of
CD8 memory T cell precursors in GVHD, critical for the production of effector T cells in response
to persistent antigen (Nat Commun 2017). However, our efforts to develop novel approaches to
selectively target alloreactive effector T cells has been limited by the lack of
understanding of why Ezh2 loss causes cell death of antigen-activated T cells. Stromal interaction
molecule (Stim) proteins, Stim1 and Stim2, are crucial dynamic endoplasmic reticulum (ER)
Ca2+ sensors and modulators of Ca2+ signals. Upon T cell receptor (TCR) ligation,
Stim1 activation causes its translocation towards the plasma membrane, where it activates the
Ca2+ channel Orai1, facilitating Ca2+ entry and driving T cell activation. Conditional Stim1
deletion inhibits GVHD in mice due to impaired effector differentiation. Remarkably,
Stim1 deletion rescues antigen-activated Ezh2-null T cells, leading to restored
production of alloreactive effector T cells in mice and severe GVHD. Therefore, we hypothesize
that: A) Ezh2 and Stim1 operate coordinately to regulate the viability and function of
antigen-driven T cells; and B) Ezh2/Stim1- regulated molecular pathway(s) are crucial for
controlling alloreactive T cell-mediated GVHD. We further establish that the role of Stim1
in Ezh2-mediated cell death is to drive mitochondrial Ca2+ (mitoCa2+) overload since conditional
deletion of the mitochondrial calcium uniporter (MCU), leads to rescue of antigen-activated
Ezh2-null T cells. To establish the therapeutic potential of these findings, we performed a
preliminary screen with an 800 compound library, finding 36 compounds that block T cell
proliferation. Amongst them was artesunate (ART), a water-soluble derivative of artemisinin
clinically approved for the treatment of malaria and known to target the Sarco/Endoplasmic
Reticulum Ca2+ ATPase (SERCA), which pumps Ca2+ from the cytosol to the ER lumen. SERCA
inhibition leads to Stim1/Orai1 activation and mitoCa2+ uptake. Preliminary
investigations show that ART treatment reduces GVHD in BALB/C mice receiving allogeneic C57BL/6 T
cells. Considered collectively, these findings suggest that Ezh2 regulates antigen-specific
effector T cell survival through modulation cytosolic Ca2+ entry, thereby limiting
mitochondrial Ca2+ loading and protecting against cell death. This hypothesis will be tested
through three specific aims. In Aim-1, we will define the mechanisms that regulate the survival
and differentiation of antigen-driven Ezh2/Stim1-null T cells. Aim-2 will determine the
molecular mechanisms by which Ezh2 deficiency dysregulates cytosolic and mitochondria
Ca2+ uptake in activated T cells. Finally, Aim-3 will examine the beneficial effect of enhancing
T cell Ca2+ load to modulate GVHD and GVL activity in mice. Completion of these experiments will
provide novel insights into T cell biology, T cell-mediated inflammatory disorders such as
GVHD and autoimmune diseases, and lead to development of novel methods for improving the
efficacy of immunotherapy for chronic infections and cancer.

Public health relevance
PROJECT NARRATIVE: Conditional deletion of either Stromal interaction molecule 1 (Stim1), which functions as crucial Ca2+ sensors and modulators in T cells, or Ezh2, which is a histone methyltransferase, leads to inhibition of alloreactive T cell-mediated graft-versus-host disease (GVHD). Surprisingly, Stim1 deletion rescues Ezh2-null T cells, leading to production of alloreactive effector T cells in mice and severe GVHD. The investigations proposed within focus on: 1) illuminating how Ca2+-driven molecular pathways are integrated with Ezh2-controlled epigenetic effects to control T cell immunity and identifying how Ezh2 deficiency dysregulates Ca2+ entry in T cells, and 2) establishing the beneficial effects of enhancing T cell Ca2+ load to modulate GVHD and GVL activity in mice.